FKBP5 AND CARDIAC ARRHYTHMOGENESIS

PROJECT SUMMARY
Atrial fibrillation (AF) is the most frequent arrhythmia. Reduced mRNA expression of FK506-binding protein 5
(FKBP5) was recently discovered in a transcriptomic study with AF patient tissues. However, the functions of
FKBP5 in heart are unknown. Preliminary studies revealed that cardiac specific loss of FKBP5 promotes the AF
development. The long-term goal of this project is to elucidate the function of FKBP5 in the heart and the
underlying arrhythmogenic mechanisms associated with the FKBP5 deficiency, with a view toward developing
new therapeutic strategies to reduce AF risk. We will test the overarching hypothesis that the FKBP5 deficiency
can enhance atrial arrhythmogenesis via a ‘double-hit’ mechanism, i.e. enhancement of Na+/Ca2+ exchanger 1 -
mediated triggered activity in cardiomyocytes, and promotion of fibrotic remodeling due to altered fibroblast
function. We will elucidate the proarrhythmic mechanisms due to cardiomyocyte-specific or fibroblast-specific
loss of FKBP5, respectively. We will also evaluate the anti-AF potential of targeting the FKBP5 pathway. The
proposed studies will unveil the critical role of FKBP5 in regulating cardiac electrophysiology and provide new
insights to molecular mechanisms of AF.

Public health relevance
Project Narrative Atrial fibrillation, the most prevalence arrhythmia, is a public health burden. The proposed work will elucidate the function of a newly discovered protein FK506-binding protein 5 (FKBP5) in heart and how the FKBP5-deficiency in cardiomyocytes and fibroblasts promotes the pathogenesis of atrial fibrillation.